Project 2: Investigating the effects of aversive interoceptive states on computations underlying avoidance behavior and their neural basis

PROJECT SUMMARY: Project 2 – Smith
Anxiety disorders are the most ubiquitous form of mental illness, affecting roughly 34% of the population. One
major factor that maintains anxiety symptoms is the continued avoidance of feared situations that are in fact
tolerable and would often improve quality of life. However, it is unknown how the aversive interoceptive states
associated with high anxiety influence maladaptive avoidance behavior – or what the neural underpinnings of
such influences are. To answer these questions, we propose to employ a previously validated inspiratory
breathing load paradigm capable of reliably inducing aversive visceral states while individuals complete two
decision-making tasks. We will use computational modeling to identify dissociable parameters underlying
learning and decision-making on an individual basis. Some important individual differences that can be
estimated within these models are values of parameters reflecting: (1) how much decisions are driven by
seeking information vs. reward, and (2) how far into the future an individual considers when making decisions
(planning horizon). Abnormal values for these parameters could drive maladaptive avoidance behavior in
anxious populations, because learning to approach uncomfortable situations requires both information-seeking
(to test expectations) and a sufficient planning horizon to anticipate that short-term discomfort can lead to long-
term benefit. Here we hypothesize that aversive visceral states reduce information-seeking and shorten
planning horizon. We further hypothesize that these effects are magnified in anxious populations. In this project
will recruit 50 low- and 50 high-anxiety participants (Overall Anxiety Severity and Impairment Scale [OASIS]
scores > 8) to test the above-stated hypotheses. Participants will complete two decision-making tasks widely
used with computational modelling – the aversive pruning (AP) task and the horizon task. They will complete
each task twice, once with and once without the unpleasant breathing load. The AP task assesses aversive
decision true `pruning' – the tendency to not evaluate distal outcomes of a possible course of action if a
proximal negative outcome is expected (i.e. effectively reducing planning horizon for policies that may have
positive distal outcomes). The horizon task assesses goal-directed information-seeking – the tendency to
strategically seek out observations to reduce uncertainty before becoming confident in the best course of
action. The AP task will be completed during fMRI. We will compare information-seeking and pruning
parameter values with vs. without breathing loads and correlate these parameters with state and trait anxiety
levels. We will also test the hypothesis that aversive states during breathing load will amplify the known neural
correlates of pruning, by increasing neural responses in subgenual cingulate, insula, and amygdala and
reducing dorsal frontoparietal activity associated with future planning. Identifying the mechanisms by which
aversive states promote avoidance will be an important first step toward designing new interventions to target
these mechanisms and improve symptoms.